Evaluation of combination CLK/DYRK (Cirtuvivint) inhibition with PARP inhibition (Olaparib) in BRCA/HRD platinum resistant ovarian cancer

PROJECT SUMMARY/ABSTRACT
Approximately 50% of patients with ovarian cancer harbor deficiencies in DNA damage repair with
either a germline/somatic mutation in BRCA1/2 or homologous recombination deficiency (HRD), and benefit
from maintenance therapy with a poly (ADP-ribose) polymerase inhibitor (PARPi) following adjuvant platinum-
based chemotherapy. Unfortunately, most of these patients will have a disease recurrence and develop
resistance to PARP therapy for an ultimately non-curable disease. However, innovative combination strategies
can be utilized to overcome resistance as well as provide therapeutic benefit, improving the lives of our
patients.
We have identified a novel first in class agent, cirtuvivint, that demonstrates single agent activity in
ovarian cancer, potentiates a unique mechanism to overcome PARP resistance, and synergizes with PARP
therapy in PARP resistant ovarian cancer models. Cirtuvivint is a CDC-like kinase (CLK) and dual specificity
tyrosine kinase (DYRK) inhibitor with suspected multiple anti-tumor mechanisms of action. Our preclinical work
has demonstrated three distinct mechanisms of activity of cirtuvivint by 1) increasing alternative splicing
events, 2) inhibiting Wnt transcriptional activity, and 3) increasing R-Loop formation.
Alternative splicing is a normal physiologic function that allows cells to change isoform-specific protein
production in response to extracellular and intracellular stimuli. Alterations are implicated in tumorigenesis and
metastasis. Cirtuvivint alters alternative splicing in the Wnt genes. Our work established that PARP resistant
high grade serous ovarian cancer cells display hyperactivation of Wnt signaling and increased TCF
transcriptional activity, leading to PARP resistance. We therefore established rationale for combination Wnt
inhibition with PARP therapy to overcome Wnt driven resistance. Additionally, we demonstrate that cirtuvivint
induces DNA damage and R-Loop formation in ovarian cancer cell lines. R-Loops are the DNA-RNA hybrids
created in DNA damage repair. Increased formation of R-Loops lends to susceptibility to PARP independent
DNA damage. Finally, a synergy with PARP inhibition and cirtuvivint was demonstrated in a panel of PARP
resistant ovarian cancer cell lines.
Based on this rationale Aim 1 will evaluate a Phase I clinical trial of combination cirtuvivint and olaparib
(PARP inhibitor) in platinum resistant ovarian cancer patients with a germline or somatic BRCA/HRD deficiency
who have previously been treated with a PARPi. We will evaluate the safety and tolerability of this combination
with the goal of establishing a recommended phase 2 dosing. Aim 2 will be focused on the evaluation of
CLK/DYRK inhibition induction of R-Loop DNA damage and the subsequent susceptibility to PARP inhibition.
We strive to elucidate the mechanism for synergy of these two drugs and introduce them as a viable
therapeutic strategy for a significant portion of ovarian cancer patients.

Public health relevance
PROJECT NARRATIVE Nearly all patients with BRCA-mutated or Homologous Recombination Deficient ovarian cancer respond to frontline chemotherapy with PARP inhibitor maintenance; however, disease recurrence and therapy resistance almost inevitably develop. Targeting Wnt signaling and RNA splicing are therapeutic strategies that could overcome therapy resistance and provide further therapeutic options to advance the care options for our patients. The proposed clinical trial and basic science research will evaluate a novel combination strategy for platinum resistant ovarian cancer patients and elucidate the suspected mechanism(s) of action.